Forkhead Transcription Factor Networks in Development, Signaling, and Disease

[unreadable] DESCRIPTION (provided by applicant): This application is to request support for a Keystone Symposia meeting entitled "Forkhead Transcription Factor Networks in Development, Signaling, and Disease", organized by Drs. Kenneth S. Zaret, Klaus H. Kaestner, and Susan E. Mango, which will be held in Midway, Utah from January 13-17, 2008. This will be the first meeting of its kind. Forkhead box (FOX) transcription factors were discovered to bind target DNA sites in compacted chromatin, where many other transcription factors cannot bind, and subsequently found to play central roles in regulatory networks that control development, signaling, metabolism, and human disease. The proposed meeting will provide a rare opportunity for cross-fertilization of ideas from very different areas of biological sciences, spanning diverse model organisms and humans, all surrounding this special class of transcription factor. It is expected that the convergence of different models systems, approaches, and thinking will allow unique new insights and advances in each of the scientific domains in which FOXA factors are studied. [unreadable] [unreadable] [unreadable]